Secretion responsive Hydrogels for Identification of Functional single T cells (SHIFT)

Project Summary/Abstract
Adoptive cell therapy has the potential to circumvent cancer immune evasion by employing patient-derived,
tumor-specific cytotoxic T-cells to attack cancer. While promising responses of advanced cases to cancer
immunotherapy bolster the optimism surrounding these therapeutic strategies, interpatient variations in treatment
responses demand a new method to select highly effective tumor-specific cytotoxic T-cells for better and safe
immunotherapy.
We propose a high-throughput, single-cell level method for identifying and recovering highly functional T cells
that secrete tumor-killing signals in the presence of tumors. Our proposed technology builds on transformational
advances in the generation of droplet emulsions, secretomics, and new hydrogel-based sensing techniques we
recently developed. In this assay, tumor-killing T cells and cancer cells will be encapsulated in pairs in a uniformly
sized, secreted factor-sensitive hydrogel droplet using a microfluidic droplet generator. The resulting isolated
reaction compartments for each cell pair will prevent the mixing of T cells' multiple secreted factors and will
concentrate them to allow sensitive detection. The hydrogel will respond to a factor secreted by functional T cells
via a dramatic size change, allowing hydrogels with active T cells to be reliably isolated from the heterogeneous
mixture using a hydrodynamic size-based particle sorting mechanism. The sorted pairs will be individually
recovered using an aspiration pipette and the hydrogel shell dissolved without cell damage, allowing for the
recovery of functional individual T cells. We propose to use this high-throughput assay, capable of screening
millions of T cells, to identify tumor-responsive T cells and to recover them for downstream analysis or
proliferation. This assay is simple, sensitive, and versatile enough to be used by a wide research community or
eventually within clinical settings for isolating and profiling rare cells with target secretory phenotypes.

Public health relevance
Project Narrative (3 sentences) The objective of the proposed study is to develop a high-throughput, cost-effective but analytical and quantitative method for identifying and recovering highly functional T cells that kill tumor cells from a large background population based on their secretory phenotype. This assay could accelerate the identification of tumor-specific T cells from a patient’s blood to more rapidly create personalized immunotherapy and enable more rapid research into the development of engineered cell immunotherapy. It could also serve as a research tool to precisely identify mechanisms of immune cell activation to help usher in better therapeutic strategies.